Akt/mTOR signaling and regulation of cell cycle in beta-cells

DESCRIPTION (provided by applicant): The capacity of β-cells to expand in response to insulin resistance is critical to develop type-2 diabetes and β-cell proliferation is a major component for these adaptive responses. The long-term goal of our previous and proposed studies under this award is the understanding of the molecular mechanisms that regulate β-cell mass with emphasis in proliferation. During the current funding period, we focused on the mechanisms by which Akt and the tuberous sclerosis complex 2 (TSC2) regulate β-cell mass and cell cycle progression. These studies identified the TSC2 and the mTOR/raptor complex (mTORC1) as important molecules regulating β-cell mass and proliferation. mTORC1 controls growth and proliferation by activation of 4E-BP and S6 kinases (S6K). Moreover, mTORC1 also mediates a negative feedback loop to attenuate Akt signaling. However, uncertainty remains as to the underlying mechanism and key downstream effectors responsible for controlled β-cell expansion by mTORC1. The objective of this application is to understand how mTORC1 targets regulate β-cell mass and proliferation. We hypothesize that β-cell mass expansion by mTORC1 signaling is mediated by a balance between two processes: activation of downstream targets and negative feedback inhibition of IRS/Akt signaling. The specific aims are (1) to establish how mTORC1 targets regulate β-cell mass expansion. These studies will evaluate the individual contributions of S6K1 and 4E-BP on regulation of cell growth and proliferation. (2) Determine how decreased Akt signaling by mTORC1-mediated negative feedback modulates β-cell mass expansion. These experiments will evaluate the role of GSK3β and FoxO on mTORC1-S6K mediated feedback inhibition on IRS/Akt signaling. This proposal will provide important insights into the molecular mechanisms that govern β-cell mass expansion by mTORC1. This information can be used to expand drug development opportunities for diabetes.

Public health relevance
Failure of β-cells to expand or adapt to insulin resistance results in type 2 diabetes. The current evidence support the concept that mTORC1 is active in states of increased insulin demand and plays a major role in β- cell adaptation to insulin resistance The goal of this application is to unravel how mTORC1 regulates β-cell mass in an effort to develop strategies to identify pharmacological targets to improve β-cell mass and function for the treatment of diabetes.